Generating evidence to improve same-day etonogestrel implant insertion for emergency contraception

PROJECT SUMMARY/ ABSTRACT
Oral emergency contraception (EC), is commonly used after recent unprotected intercourse to avoid undesired
pregnancy, but does not provide ongoing contraception. Rigorous data allow for use of intrauterine devices
(IUDs) as both EC and ongoing contraception, but EC efficacy data on use of the etonogestrel (ENG) implant,
is lacking. The CDC Selected Practice Recommendations for Contraceptive Use support initiation of the ENG
implant if oral levonorgestrel (LNG) is given concomitantly for EC. This recommendation lacks supporting
evidence and serves as a barrier to method initiation, as oral LNG is not typically available in clinics when
clients desire an implant. Additionally, oral LNG efficacy decreases in higher body mass index (BMI) users and
the role of BMI on efficacy with co-administered oral LNG and the ENG implant is unknown. As the ENG
implant is also a synthetic progestogen with a rapid rise and consistent systemic levels, it could plausibly serve
as stand-alone EC or increase the efficacy of oral LNG with co-administration. Moreover, the EC mechanism of
action, which is related to ovulatory suppression with oral EC, may differ if the implant is initiated with or
without oral LNG, impacting efficacy in mid cycle users. This study addresses the following research gaps
around use of the ENG implant for EC that serve as barriers to provider comfort with these options: efficacy
with and without oral LNG, efficacy differences by BMI, and ovulation frequency with and without oral LNG.
We propose a randomized, placebo-controlled, non-inferiority study to determine if the ENG implant alone is no
worse than the ENG implant + oral LNG for EC, using a 3.5% non-inferiority margin. We will include clients
who present to Planned Parenthood Association of Utah clinics with report of unprotected intercourse within 72
hours who desire EC. Eligible EC clients interested in an implant with a negative pregnancy test will be
allocated 1:1 to a study group: (1) ENG implant + oral LNG or (2) ENG implant + placebo. Our experienced
research staff will follow up with participants for 4-week efficacy data as primary outcome. Our aims include:
(1) To compare the efficacy of the ENG Implant + oral LNG to the ENG Implant + placebo for EC in 790
participants assessed by pregnancy status four weeks after implant placement, (2) To compare pregnancy risk
by BMI category (we anticipate half of the 790 participants will have a BMI ≥25) between and within the ENG
Implant + oral LNG and the ENG Implant + placebo groups, and (3) To evaluate ovulation frequency within 5
days of insertion of ENG Implant + oral LNG or ENG implant + placebo in 202 participants who are mid cycle
(day 7-14 post menses) at time of enrollment assessed by serum progesterone levels and urine fertility monitor
results. Our short-term goal is to expand evidence on the efficacy of implant initiation with or without oral LNG
to meet the needs of EC clients. Our long-term goals are to develop evidence-based clinical guidelines to
inform global contraceptive practices, allow for equity in LARC counseling at the time of EC, and support
reproductive autonomy for people to achieve to their life goals.

Public health relevance
PROJECT NARRATIVE We know that IUDs are highly effective to prevent pregnancy when used for emergency contraception (following unprotected intercourse in the last 3 days), but lack data for those who desire an etonogestrel (ENG) contraceptive implant in this situation. This proposal will identify the most effective way to start an implant for emergency contraception using a randomized controlled trial comparing pregnancy risk between those receiving the implant vs. the implant plus oral emergency contraception. Data from this project will inform clinical practice and add another option, the implant, for those desiring a long acting, highly effective contraceptive method when they present for emergency contraception.